A pilot sensor-controlled digital gaming intervention with real-time behavior tracking to motivate self-management behaviors in older adults with heart failure

PROJECT SUMMARY/ABSTRACT Despite significant advances in treatment, heart failure (HF) continues to be the leading cause of hospitalizations among older adults in the U.S., with an estimated annual cost of $32 billion. Poor self-­ management in older adults with HF causes poor adherence to behavior recommendations, delays in recognizing HF health crises and seeking clinical assistance, leading to frequent hospitalizations, impaired functional status, and poor quality of life. However, recent large-­scale studies of interventions designed to support HF self-­management have suffered from challenges of lower than anticipated recruitment as participants were required to travel to intervention sites, being compared with usual care programs that were exceptional but expensive and human resource-­intensive or failure to engage participants till end of study periods. One promising approach is the use of sensor-­controlled digital games (SCDG), which offer affordable, portable, scalable tools to facilitate engagement in HF self-­management behaviors that show the poorest adherence—weight monitoring and physical activity—while being enjoyable and easy to use. The primary goal of this study is to obtain initial efficacy data and undertake a comprehensive feasibility assessment of a SCDG intervention that synchronizes with a Bluetooth-­enabled weight scale and activity tracker to activate game rewards and feedback based on older adult HF participants’ real-­time weight monitoring and exercise behaviors. In Aim 1, we will assess the preferences, and acceptability of the SCDG among 10 older adults with HF during formative design process. In Aim 2, to motivate participants’ engagement in HF self-­management behaviors, we will develop a SCDG (“Safe at Home”) informed by Fogg’s behavioral model, utilizing a narrative in which the goal is to help an avatar in the game avoid re-­hospitalization and assess its? usability. Aim 3 will evaluate the initial efficacy of the SCDG intervention for primary outcome of rate of engagement in HF self-­ management behavior of weight-­monitoring and secondary outcomes of physical activity engagement, HF self-­ management-­knowledge, and self-­efficacy, HF-­functional status, hospitalization, and quality of life. For this study, we will recruit older adults diagnosed with the New York Heart Association’s HF classification I to III from out-­patient HF settings in central Texas, and we will randomize 44 patients to either the SCDG intervention group that will receive sensors tracking weight monitoring and activity and play the SCDG on a mobile smartphone for 12 weeks or a control group that will receive sensors and an app tracking activity and weight monitoring, and standardized written HF educational modules. Aim 4 will determine the feasibility of the SCDG intervention and will form the basis for designing a future larger and longer randomized controlled clinical trial. Our project will generate much needed insight and guidance for digital gaming solutions to motivate adherence to HF self-­management behaviors and improve the health outcomes of older adults with HF.

Public health relevance
PROJECT NARRATIVE Older adults with heart failure (HF) face significant healthcare burden and suffering, but effective HF self- management behaviors can reduce their hospitalizations and mortality. We propose the design and development of a sensor-controlled digital game intervention enhanced by real-time behavior-tracking sensors to improve older adults’ knowledge, skills, and motivation to engage in the important HF self-management behaviors of weight monitoring and physical activity. This project will generate much needed insight and guidance regarding the use of digital gaming as an affordable, portable, scalable technology to improve older adults’ self-management of HF and will potentially reduce the burden of HF.